Renal Metabolism in AKI

PROJECT SUMMARY
Acute kidney injury (AKI) in the setting of sepsis is frequently observed and is a significant clinical
problem with high levels of morbidity and mortality. One of the major barriers to the progress in
the field is the lack of understanding of the pathogenesis of AKI in this setting. The specific aims
of this proposal is to investigate the changes in kidney metabolism in sepsis associated AKI that
impact injury and recovery of kidney tubules which are the primary site of injury in sepsis.
The research strategy is to employ a comprehensive investigative approach for an integrative
understanding of pathogenesis of sepsis associated AKI, using the clinically relevant cecal ligation
and puncture model of sepsis. The methods will include molecular techniques to assess tubular
metabolism, mitochondrial bioenergetics, ATP, reactive oxygen species generation and electron
microscopy to assess mitochondrial morphology and dynamics, metabolic imaging and
physiological techniques such as in-vivo glomerular and tubular function at a single nephron and
whole kidney level. These investigations will provide important mechanistic insights into the
pathogenesis of sepsis-associated AKI and identify novel therapeutic targets. The insights
obtained will be valuable beyond the model studied given the wide-spread implications of
metabolic dysfunction in kidney disease.

Public health relevance
Acute kidney injury in the setting of sepsis is common in critically ill patients and is a significant medical problem with a poor prognosis. Lack of understanding of the mechanisms that lead to kidney injury is a major barrier to progress in this area and improvement of outcomes in patients. This proposal aims to understand the mechanisms leading to kidney injury and has the potential to identify novel therapeutic targets for patients with sepsis associated kidney injury.